Neural Speech Tracking in Infants: Associations with Hearing, Environment, and Language

PROJECT SUMMARY
While most infants acquire language with ease, congenital hearing loss commonly causes deficits in speech-
language development. Additionally, about 40% of infants with hearing loss have a physical or developmental
disability that prevents reliable behavioral responses. Therefore, there is a critical need for an objective measure
(i.e., neural biomarker) of speech processing to improve the clinical management of infants and children with
hearing loss. Neural speech tracking (NST) is a novel electrophysiological (EEG) technique that quantifies
hierarchical encoding of speech from low-level acoustic features (fundamental frequency, spectrogram, speech
envelope, acoustic onset) to high-level content (phonetic, prosodic, and semantic). However, little is known about
the developmental trajectory of NST while infants are acquiring language and the impact of hearing and
environmental factors. To address these gaps, we will conduct a prospective longitudinal study of NST in full-
term infants at 1, 6, and 12 months of age. Testing will include assessment of hearing and the environment
(social risk, shared reading, home and language environment) as they relate to language outcomes. The specific
aims of the study are to evaluate hearing, environmental factors, and language outcomes (Aim 1), examine the
developmental trajectory of NST and spontaneous EEG (Aim 2), and examine relationships among hearing,
environment, NST and spontaneous activity, and language outcomes (Aim 3). The central hypothesis is that
NST will be modulated by age, hearing, and environmental factors and that NST will be correlated with later
language outcomes. The expected outcomes are that hearing and environmental factors will have a measurable
impact on NST and that NST will prove to be a neural biomarker of language acquisition. The proposed research
will advance the field of hearing research by providing a strong foundational knowledge of the developmental
trajectory of NST and the impact of hearing and environment as the infant brain assembles functional networks
that support speech processing. To improve clinical management of infants and children with hearing loss – a
key mission of the NIDCD – a neural biomarker of how speech is encoded in the brain is essential. The K23
award will provide structured training and experience in three core areas: 1) Impact of the Environment on
Language Acquisition, 2) Advanced Neurophysiological Techniques, and 3) Scientific Dissemination,
Grantsmanship, and Biostatistics. The proposed study will take place at Cincinnati Children's Hospital under
primary mentorship of Dr. Hunter along with an accomplished team of experts in early language development
and assessment, socioenvironmental risk, NST and spontaneous EEG, auditory neurodevelopment,
computational neuroscience, and biostatistics. The training will build upon Dr. Blankenship’s clinical and research
experience and ensure that she achieves her long-term career goal to become an independent clinician-scientist
using translational methods to improve the diagnosis and treatment of infants and children with hearing loss.

Public health relevance
PROJECT NARRATIVE Neural speech tracking (NST) is an innovative electrophysiological technique that quantifies encoding of continuous natural speech, yet little is known about the developmental trajectory in infants and associations with hearing, environment, and language. It holds great promise as a neural biomarker of language acquisition providing information about maturation of speech processing, to determine if rehabilitation/treatment is needed, and to benchmark progress with hearing devices (i.e., hearing aids and cochlear implants). The proposed study is congruent with the NIDCD Strategic Plan “Advancing the Science of Communication to Improve Lives” through 1) increased knowledge of NST in typically developing infants (i.e., enhance understanding of normal function; Theme 1), and 2) characterizing the impact of individual differences in hearing, environment, and language on NST (i.e., precision medicine; Theme 3).